Genomic mechanisms of violent juvenile aggression

PROJECT SUMMARY
Violent aggressive behavior in children has life-long consequences for perpetrators, victims, their families, and
society. Yet the biological bases of juvenile aggression remain largely unknown. This gap in knowledge persists
due to a lack of tractable models in which juvenile aggression can be readily observed and manipulated. The
proposed project takes an innovative, integrative approach to address this pressing knowledge gap using a novel
animal model. Alongside the experimental tractability of classic fish and amphibian models, poison frog juveniles
are highly aggressive, providing a powerful opportunity to understand the genomic bases of juvenile aggression.
We test the central hypothesis that distinct mechanisms mediate the acute performance of, propensity for, and
consequences of aggressive experiences. We pursue two complementary research directions to (1) uncover the
mechanistic bases of individual variation and developmental shifts in aggression, and (2) probe the genomic and
behavioral consequences of aggressive experiences for both perpetrators and victims. To optimize risk and
reward, we tackle these questions from multiple angles, combining unbiased, exploratory approaches with
characterization and manipulation of canonical candidates important for social behavior across vertebrates,
including humans. Experiences of aggression have long-lasting individual and societal consequences and
mechanistic research will have a significant positive impact by illuminating causes, consequences, and potential
treatments for violent aggression among the youngest members of our society.

Public health relevance
The overall objective of the proposed project is to study the biological basis of violent juvenile aggression in a novel animal model. This work has implications for public health as experiences of aggression have long-lasting individual and societal consequences and disorders with high co-morbidity of aggressive behavior are on the rise, but a tractable model system is currently lacking. Research outcomes will have a significant positive impact by illuminating causes, consequences, and potential treatments targets for violent aggression among the youngest members of our society.